The Role of Financial Strain in Adult Alcohol, Cannabis, CNS Depressant and Polysubstance Use, and Mitigating Effects of Earned Income Tax Credit Policies: a Longitudinal Study using PATH data

PROJECT SUMMARY/ ABSTRACT
Financial strain and substance use are widespread in the United States (US), as many adults struggle to meet
basic financial needs. Financial strain is distinct from its sources (e.g., job or income loss), as perception of strain
may be necessary to produce a stress-response that prompts substance use as a coping mechanism. Studies
examining the relationship between financial strain and substance use have focused on the association between
financial strain and alcohol use, or acute financial strain due to sudden changes in job or income. However, there
is a need to examine whether the relationship between financial strain and substance use varies by substance,
and the duration of financial strain (i.e., acute financial strain due to sudden job or income loss, chronic financial
strain due to persistent deprivation, or intermittent financial strain due to repeated periods of economic
insecurity). Anti-poverty programs such as the federal Earned Income Tax Credit (EITC) may provide an
opportunity to reduce financial strain and subsequent substance use by providing financial support to low-income
populations. The current R36 proposal seeks to provide novel insights about the associations between acute,
chronic, or intermittent financial strain and cannabis, CNS depressant, alcohol, and polysubstance use, and
whether federal EITC eligibility alters these relationships. To achieve these goals, we propose three aims that
will leverage individual- and state-level data from 5 waves (2013-2019) of the Population Assessment of Tobacco
and Health study, a longitudinal cohort of >30,000 US adults. Aim 1 will examine the association between
financial strain and cannabis, CNS depressant, alcohol, or polysubstance use at subsequent time points using
parametric g-computation, accounting for time-varying confounding, and examining effect modification by sex.
Aim 2 will create exposure trajectories of financial strain (i.e., none, acute, chronic, and intermittent) across four
waves of data collection, and examine the risk of cannabis, CNS depressant, alcohol, or polysubstance use at
Wave 5 using a mixed model to adjust for substance use trajectories and recency of financial strain. Aim 3 will
examine whether federal EITC eligibility is associated with short-term changes in financial strain, cannabis, CNS
depressant, alcohol or polysubstance use, and whether financial strain mediates the relationship between federal
EITC eligibility and substance use, examining effect modification by sex and state EITC. This project will advance
NIDA’s research priority to support dissertation research examining social factors that influence drug use
outcomes, and determine how policies affect drug use trends. Findings from this R36 study will help identify
individuals at risk for substance use, inform policies seeking to alleviate financial strain, and will inform a future
K award application. The proposed project and mentorship team will provide the principal investigator with the
opportunity to develop expertise at the intersection of health economics, substance use epidemiology, and policy
research, in pursuit of her long-term goal of becoming an independent researcher at an academic institution.

Public health relevance
PROJECT NARRATIVE Individuals experiencing financial strain (i.e., an inability to meet basic financial needs) may be more likely to use substances as a coping mechanism for the stress associated with financial strain, but they may also be eligible for financial support from anti-poverty programs such as the federal Earned Income Tax Credit (EITC). The few studies that have examined the relationship between financial strain and substance use have largely focused on alcohol and on acute financial strain due to sudden job or income changes, and have not explored whether financial support from federal policies such as EITC affect this relationship. Using 2013-2019 data from the Population Assessment of Tobacco and Health study, this project will examine: 1) whether financial strain is associated with cannabis, CNS depressant, alcohol, or polysubstance use, 2) how the duration of financial stain (i.e., acute financial strain due to sudden job or income loss, chronic financial strain due to persistent deprivation, and intermittent financial strain due to repeated economic insecurity) affects substance use, and 3) if financial support offered by the federal EITC may lower the risk of financial strain and subsequent substance use.